Nutritional Niches within Supragingival Biofilms

PROJECT SUMMARY / ABSTRACT
The bacteria that colonize the oral cavity, forming biofilms on surfaces such as the hard tissues of teeth,
participate in complex exchanges with other microbes inhabiting the same niche. One such example is the
relationship between Streptococcus mutans, one of the primary drivers of dental caries development, and other
oral commensal streptococci species. Organic acids produced by S. mutans, an end product from the
fermentation of dietary carbohydrates, accumulate and are concentrated within microcolony-like biofilm
structures that are the sites of enamel demineralization. Encasing the microcolonies are oral commensal
streptococci – thus, understanding how these structures form, the interactions that occur between S. mutans
and other oral streptococci that enclose them, and development of new strategies/targets to disrupt these
structures is of critical significance to the field of oral health. Our group has begun to address these needs
through characterization of S. mutans gene expression when it is cocultured with other oral bacteria and have
made several crucial observations such as alterations to the S. mutans transcriptome through a specific,
characterized pattern only in the presence of oral commensal streptococci, and not with other disease-
associated streptococci or oral non-streptococci. One such change is in the expression of phosphotransferase
systems (PTS) for specific carbohydrate uptake and utilization. During growth in coculture, both S. mutans and
oral commensal streptococci gene expression stratifies into different carbohydrate utilization preferences,
suggesting that each species partitions into a different nutritional niche during the interaction. However, these
conclusions are only based on transcriptomic datasets and require further experimentation to validate. Our
central hypothesis is that during active competition, health- and disease-associated oral streptococci modify
carbohydrate utilization preferences via gene expression changes as to not compete for the same
carbohydrate source. Our objective is to validate this hypothesis though using functionalized carbohydrates for
click chemistry that will allow for single cell analysis of carbohydrate utilization during super-resolution
microscopy imaging of mixed-species biofilms, as well as to validate/confirm our findings through genetically
engineered mutants in both S. mutans and oral streptococci. Our long-term goal is to be able to manipulate
these interactions through either prebiotic/probiotic strategies and/or therapeutic interventions to target
pathways that selectively remove S. mutans from oral biofilms while leaving health-associated, commensal
species intact. Included in our approach are research objectives that: i) explicate nutritional niches between
health- and disease-associated oral bacteria, ii) exploit nutritional niches to alter microbial ecology through oral
streptococci interactions, and iii) elucidate partitioning of the oral microbiome by specific carbohydrate
utilization preferences. Together, this proposal will strengthen our understanding of the interconnectedness of
the oral microbiome while working to answer new and relevant questions in understanding how intermicrobial
interactions can drive dysbiosis of a healthy microbial community, eventually leading to disease (caries)
formation.

Public health relevance
PROJECT NARRATIVE All microbes have preferred carbon sources, such as dietary carbohydrates, that they compete for with other microbes within a shared habitat. This study investigates how carbon source preference shifts at the single-cell level between microbes that are growing as part of a mixed-species community, such as those found in oral biofilms attached to the tooth surface with associated health-relevant outcomes like the development of tooth decay (dental caries).